Impact of the vaginal microbiome on topical HIV pre-exposure prophylaxis (PrEP)

Globally, young women represent one of the most vulnerable groups at risk for HIV acquisition highlighting the
need for safe, acceptable and effective prevention products. Outcomes in pre-exposure prophylaxis (PrEP)
clinical trials have been uniformly disappointing in this high-risk age group, reflecting both behavioral and
biological characteristics. The efficacy of PrEP reflects a balance between host susceptibility to HIV and the
concentration of drug present in host target cells at the time of exposure. One of the most important biological
factors that modulates both the risk of HIV acquisition and the pharmacokinetics and efficacy of topically
delivered PrEP products is the vaginal microbiome. Recent studies highlight the complex mechanisms by which
individual bacteria and their metabolic products adversely affect the pharmacokinetics of several different PrEP
drugs by competing with human cells for drug uptake, inhibiting drug transport into human cells, or metabolizing
drugs. Moreover, bacterial vaginosis, which is common in adolescent and young women, is associated with
increased HIV risk, possibly reflecting mucosal inflammation. However, the precise mechanisms linking dysbiosis
with inflammation and the cumulative effect of the microbiome on PrEP pharmacokinetics are not defined. This
application will address this critical knowledge gap and test the overarching hypothesis that vaginal dysbiosis in
adolescent and young adult women reduces PrEP efficacy by promoting mucosal inflammation, increasing HIV
risk, and decreasing local drug bioavailability. We will use cutting edge technologies including flow cytometry
based bacterial cell sorting of immunoglobulin-coated bacteria combined with 16S rRNA sequencing (IgSeq),
metagenomic and metatranscriptomic sequencing to evaluate the link between vaginal dysbiosis and mucosal
inflammation. Vaginal swabs will be collected from adolescent and young women with symptomatic bacterial
vaginosis (BV) before and after standard of care treatment and from asymptomatic controls (no BV) who are
frequency matched for age, race/ethnicity and contraceptive use. We will characterize the total bacterial
population and the IgA and/or IgG coated and uncoated bacteria and correlate findings with measures of genital
tract inflammation including gene expression in vaginal biopsy tissue. We predict that the composition of Ig
coated bacteria will differ before and after BV treatment and compared to controls and will identify bacteria that
drive genital tract inflammation. Using the clinical samples, we will determine the cumulative effects of bacterial
communities and their metabolome on tenofovir-based PrEP (including tenofovir and its prodrugs), assess which
mechanisms dominate, and explore potential interventions that might promote more consistent drug
pharmacology. We will also evaluate “next-generation” PrEP products including integrase inhibitors. Together,
these results will provide rationale for the selection, dosing and formulation of drugs alone or in combination for
optimal prevention of HIV in young women.

Public health relevance
Epidemiological and clinical studies demonstrate that the vaginal microbiome and dysbiosis increase the risk for HIV acquisition and may modulate antiretroviral drug transport and metabolism thus adversely impacting the efficacy of pre-exposure prophylaxis (PrEP) formulations. Defining the underlying mechanisms will lead to the development of new strategies for HIV prevention and will facilitate the selection, dosing and formulation of products for optimal prevention in one of the most vulnerable cohorts-adolescent and young adult women. These studies are designed to maximize the public health impact of topical PrEP by addressing the need to identify products that retain effectiveness in the setting of real-world adherence and among women with different microbial communities.